Admin Core

ABSTRACT – CANCER CENTER ADMINISTRATION
The Cancer Center's Administrative Office plays a critical role in providing resources and expertise to support
strategic initiatives and ongoing operations. Under the leadership of the Director, Dr. Garth Powis, the Cancer
Center administration leads an Administrative Team (AT) and a Shared Resources Team (SRT). The AT is led
by Adrienne Crown, J.D., Associate Director of Administration, who oversees central administrative support. The
SRT is led by Craig, Hauser, Ph.D., Associate Director of Shared Resources, who oversees and manages the
Shared Resources and their equipment. The Administrative Office leadership is supported by Administrative
Coordinators and a Shared Resources Coordinator. The Administrative Office works to prevent duplication and
ensure integration and coordination with the larger Institute structure, and it acts as a liaison to all Sanford
Burnham Prebys Medical Discovery Institute departments. Key activities overseen by the Administrative Office
include: (1) fiscal management and strategic planning, (2) grants management, (3) Shared Resource oversight
and support, (4) planning and evaluation oversight, (5) CCSG membership processes and activities, (6) strategic
communications, (7) general administration and events coordination, (8) communication outreach and
engagement, (9) pilot project administration, (10) faculty recruitment management, and (11) space management.
The Cancer Center's small administrative staff works with the Institute's departments to assure that all Center
needs are being met.